Pregnancy and cardiovascular health in caring for women with systemic lupus erythematosus

Project Summary
Systemic lupus erythematosus (lupus) is a chronic, multisystem, autoimmune disease that disproportionately
affects women (approximately 8 to 1), and it is typically diagnosed during the reproductive years.
Preeclampsia, a serious pregnancy complication characterized by high blood pressure, is 3 times more
common in women with lupus compared with other women, but there has been limited research into how
medical management of lupus during pregnancy could prevent preeclampsia and other hypertensive disorders
of pregnancy (HDP). Hydroxychloroquine (HCQ) is a lupus maintenance drug that women are recommended
to continue during pregnancy, but for women with well-controlled lupus who are not taking HCQ prior to
pregnancy, recommendations are less clear. HCQ helps manage lupus symptoms during pregnancy; it may
also decrease the risk of HDP although the current literature is inconsistent, likely due to small sample size in
prior studies. On the other hand, women who conceive with active lupus often need to change their treatments
to drugs that are considered safe during pregnancy. There is limited evidence that suggests use of high dose
corticosteroids may increase the risk of preeclampsia, but less is known about other drugs, such as
azathioprine, or about the effects of different treatments on HDP more broadly. Of additional concern, in the
general population, history of HDP has been associated with hypertensive-related outcomes, such as kidney
and cardiovascular disease, postpartum and later in life. This relationship is of particular concern for women
with lupus who are already at substantially higher risk of hypertensive-related outcomes during their
reproductive years compared to the general population. Pregnancy itself may even increase the risk of these
outcomes among women with lupus. Thus, pregnancy history may serve as an important marker to identify
women with lupus at the greatest risk of hypertensive-related outcomes. We will address current gaps in
knowledge through the following aims: 1) To what degree does HCQ decrease the risk of HDP among women
with well-controlled lupus before pregnancy, 2) Which approaches to medical management of lupus decrease
the risk of HDP among women with active lupus before pregnancy, and 3) To what degree does pregnancy
history predict hypertensive-related outcomes, including kidney and cardiovascular disease, outside of
pregnancy? We will address these aims using 17 years of data from Merative™ MarketScan® Research
Databases, which will include around 4,700 pregnancies to women with lupus. The data include de-identified,
individual-level enrollment records and inpatient, outpatient, and drug claims data for a cohort of privately
insured individuals. The proposed work is directly aligned with the goals for this request for applications.
Expected outcomes from the proposed work will 1) contribute evidence directly relevant to treatment decisions
for women with lupus during pregnancy, and 2) provide insights into the role pregnancy history may play in
identifying women with lupus at high risk for future hypertensive-related outcomes.

Public health relevance
Public Health Relevance Women with systemic lupus erythematosus (lupus) are at substantially higher risk of hypertensive-related outcomes, including hypertensive disorders of pregnancy, during their reproductive years compared with women in the general population. Results from the proposed study will help inform discussions of treatment options to decrease the risk of hypertensive disorders of pregnancy among women with well-controlled and with active lupus at conception. In addition, results from the proposed study will determine the role of pregnancy history in identification of reproductive-aged women with lupus at high risk for hypertensive-related outcomes, including kidney and cardiovascular disease, outside of pregnancy.